Broadly neutralizing SARS-CoV-2 peptidic knobs

Abstract
Targeted therapeutic agents range in size from very small organic molecules (100’s of Da) to
protein-based molecules like monoclonal antibodies (~150,000 Da). Small disulfide bonded
peptides have evolved in many species, including plants and animals, to have ideal
pharmacological properties including high affinity target binding, stability to proteases, heat and
other stresses. Such peptides include “cyclotides” or “knottins” which can inhibit enzymes, ion
channels, and GPCRs with high potency and are often the major active component of venoms
of many predator organisms. We have uncovered convergent evolution between ultralong third
complementary determining regions (CDR H3s) in the heavy chain of an unusual class of cow
antibodies and cyclotide/knottin peptides. We can produce these “knob” peptides in microbial
systems and they retain the binding and potency properties of the parent antibody. These tiny
peptide-based molecules are small (~4-6 kDa), highly stable, and can bind targets at
subnanomolar KD. We have already developed a panel of virus neutralizing knob peptides
against SARS-CoV-2 which bind unique epitopes, and some of which maintain high affinity
binding to various SARS-CoV-2 variants, including the recent ‘delta’ and ‘omicron’ strains. The
high stability, potency, and straightforward manufacturing path enables multiple routes of
administration, potentially including inhaled or intranasal delivery, which could be very important
prophylactic or treatment in the current or future coronavirus pandemic. Our goals in this project
are to further develop the technology to identify peptidic knob domains, expand our panel of
knobs against SARS-CoV-2 variants and other coronaviruses like MERS-CoV and SARS-CoV-
1, understand the structural basis of their binding, and validate their activity in vitro and in vivo.
The knobs identified here can potentially be used as monotherapy or combination therapy in the
current or a new coronavirus pandemic, and will be a valuable new therapeutic class to add to
the arsenal against coronavirus disease.

Public health relevance
Project Narrative The SARS-CoV-2 virus is a pandemic causing widespread COVID-19 respiratory disease and death globally. We have discovered that cow antibody CDR H3 “knob” domains can be made as independent small peptides, and have identified several such peptides that potently bind and neutralize the SARS-CoV-2 virus and its variants, including delta and omicron. We aim to discover a larger panel of these knob peptides and evaluate their efficacy as single agents, cocktails, and bispecific molecules on SARS-CoV-2 neutralization; this work could impact the current SARS-CoV-2 outbreak, as well as future novel coronavirus outbreaks.